Strategic Treatment Assessment with Youth (STAY): A measurement-based care approach to promote treatment retention among racial and ethnic minoritized youth with depression or suicide risk

ABSTRACT
Despite high rates of need, REM youth are significantly more likely to prematurely dropout of mental health
services as compared to their White peers. This is due in part to poor therapeutic alliance and concerns about
treatment relevance and acceptability. Existing engagement interventions are limited, with few addressing
treatment retention for REM youth at risk for depression and suicide. Measurement-based care (MBC) is the
use of patient-reported progress data throughout mental health treatment to promote collaborative, patient-
centered treatment plan adjustments. MBC is an outstanding candidate to improve treatment engagement due
to its focus on personalized treatment and is also highly effective when integrated in depression treatment. Yet,
MBC could be tailored to better address the unique needs of REM youth. MBC has not been examined as a
treatment engagement strategy for REM youth with depressive symptoms or suicide risk. Further, no clinical
protocols, guidelines or training supports exist to facilitate clinician use of MBC with REM youth and their
caregivers. Based on past research, we have developed a theoretically-driven, culturally-tailored MBC
approach, Strategic Treatment Assessment for Youth (STAY). STAY targets therapeutic alliance and treatment
relevance and acceptability (concerns particularly relevant to REM youth and their caregivers) to improve
treatment retention, depression symptoms and suicide outcomes. Pilot data suggest STAY is acceptable,
feasible, and appropriate. In Aim 1, we will refine the preliminary STAY protocol and implementation plan to
support delivery in a wide variety of clinical contexts. A user centered design approach including cognitive
walkthroughs and lab-based testing with N=12 expert stakeholders will be used to rapidly refine prototype
versions for usability. In Aim 1, we will also develop STAY instrumentation for clinician fidelity, knowledge,
skills, and attitudes to be piloted in Aim 2. Aim 2 will involve a pilot effectiveness-implementation Hybrid Type 2
trial to examine the feasibility, acceptability, appropriateness, and initial effectiveness of STAY as compared to
an active control condition (MBC As Usual). Clinicians (N=20) at three community mental health clinics will be
randomly assigned to STAY or MBC As Usual and N=60 adolescent patient/caregiver dyads (Total N=120)
who meet inclusion criteria will also be recruited to participate. Initial effectiveness of STAY on treatment
engagement mechanisms (treatment alliance, relevance), service outcomes (treatment attendance,
engagement, completion) and youth outcomes (depression, suicidality) will be assessed. This pilot will inform
optimal study procedures, measures, and sites for a fully-powered Hybrid Type 2 trial. Disparities in depression
and suicide rates are a national public health crisis. This project offers an innovative, culturally-tailored
approach to retain REM youth in mental health services, reduce disparities and improve patient outcomes. This
study contributes to NIMH Strategic Goal 4.3 to improve the public health impact of mental health services
received by diverse communities by improving care quality for REM youth at risk for depression and/or suicide.

Public health relevance
PROJECT NARRATIVE: Despite high and rising rates of adolescent depression and suicidal thoughts and behaviors, racial and ethnic minoritized (REM) youth are significantly less likely to remain in mental health services than their White peers. Measurement-based care (MBC) is an evidence-based practice that holds promise to promote mental health treatment engagement, but has not been tailored for REM youth. Scientific discovery about how to retain REM youth with depressive symptoms and/or suicide risk in treatment by using a culturally-tailored approach to MBC could reduce disparities in mental health treatment access and outcomes, reducing suffering among this vulnerable population.